Development of a vaccination platform for emerging flavivirus infections

Project Summary:
The Flavivirus genus (referred to as flaviviruses) consists of numerous emerging and re-emerging
global pathogens of critical human significance. Endemic and emerging flaviviruses like dengue virus (DENV),
Powassan virus (POWV), Zika virus (ZIKV), West Nile virus, Japanese Encephalitis virus and Yellow fever
virus continue to spread and cause significant human disease. We have used RNA structural data from a
conserved 3’ untranslated region (UTR) pseudoknot called xrRNA1 to develop an attenuation approach in a
highly conserved structural region of the flavivirus 3’UTR for vaccine development. This approach allows us to
1) swap out flavivirus structural genes in our clone to rapidly develop chimeric, attenuated flavivirus vaccines
for mosquito-borne flaviviruses and 2) provides a conserved site for attenuation for tick-borne flaviviruses like
POWV.
Based on our preliminary data, we hypothesize that xrRNA1-mutant, attenuated flavivirus vaccines will
be safe, immunogenic, and provide protection from challenge in murine models of flavivirus disease. The
objective of the proposed studies is to complete pre-clinical development of the attenuated flavivirus vaccine
approaches. We will complete our proposed work in three aims that will evaluate immunologic and virologic
outcomes following virus challenge after vaccination with candidate ZIKV vaccine (Aim 1), DENV vaccine (Aim
2), and POWV vaccine (Aim 3).
We have recently published our data showing attenuation and immunogenicity of mutant xrRNA1 ZIKV
(X1) in pregnant and non-pregnant mice. In this proposal, we will first evaluate the efficacy of ZIKV X1 vaccine
in pregnant and non-pregnant mice challenged with ZIKV and DENV. These studies will allow us to evaluate
ZIKV vaccine efficacy during pregnancy and evaluate the role of ZIKV vaccination in DENV disease
enhancement. Next, we will use the attenuated, ZIKV vaccine platform developed in our laboratory using
xrRNA1 structural data, insert chimeric pre-membrane and envelope structural genes from DENV1-4 and
evaluate the attenuation, immunogenicity and efficacy of monovalent and quadrivalent DENV1-4 vaccine
candidates. Given the complexity of DENV infection, we will evaluate disease enhancement and
immunodominance in our quadrivalent vaccines along with efficacy. Third, we will expand our attenuation
strategy in the X1 structure to tick-borne flaviviruses by utilizing our recently defined secondary structure of the
POWV 3’UTR. Using POWV mutant vaccine candidates with targeted mutations in the X1 structure, we will
characterize attenuation, immunogenicity, and efficacy of a POWV vaccine approach in a murine model of
disease. The proposed studies will begin to translate our structural understanding of xrRNAs in the flavivirus
3’UTR into potential vaccine candidates. Moreover, this project will initiate studies focused on developing a
platform for vaccine development for emerging flavivirus infections.

Public health relevance
Project Narrative The proposed work will develop a platform for flavivirus vaccine development using a cloning approach with focused attenuating mutations in a conserved region of the 3’ untranslated region (UTR) of flaviviruses. The goal of the project is to use a common strategy of attenuation in the 3’ UTR to develop an attenuated vaccine approaches for endemic and emerging flavivirus infections. If completed as outlined, our approach will allow for rapid development of chimeric, attenuated flavivirus vaccines for emerging infections.